School Environment as a Social Driver of Youth Mental Health Trajectories in Mwanza, Tanzania

SUMMARY. Mental health problems are a leading cause of disability among children worldwide and in
Tanzania where research has documented high rates of youth depression, anxiety, and suicide, 43% of the
population is under the age of 15, and access to treatment services is limited. One theoretically important
social driver of youth mental health is the primary school environment. Schools have the potential to foster
cognitive, emotional, and social functioning that, in turn, promotes mental wellbeing. Further, school
experiences are thought to play a critical role in shaping the adaptive systems that enable resilient functioning
in youth who have experienced adversities. As such, intervening to improve school determinants holds promise
as a potentially effective “upstream” prevention approach. Our understanding of what to target for intervention
is limited, however, because has almost no rigorous longitudinal research has been conducted to identify
specific malleable determinants of the school environment that shape mental health. Our long-term goal is to
develop a multicomponent intervention that leverages positive aspects of schools to promote the mental health
of youth in Tanzania. Specific aims of the study are to: (1) develop a culturally meaningful set of measurement
tools to comprehensively assess the primary school environment in Tanzania; (2) examine how different
dimensions of the school environment work to impact mental health trajectories of Tanzanian youth; and (3)
determine how features of the school environment can be leveraged to buffer the impacts of exposure to
childhood adversities (violence exposure and deprivation). To accomplish these aims, we will collect data from
teachers, caregivers, and students in 60 randomly selected primary schools in the Mwanza region of Tanzania.
For aim 1, we will develop a robust set of observational and survey measures of the school environment, using
qualitative research to investigate cultural relevance and a psychometric study to examine the validity and
reliability of the adapted measures. To accomplish Aims 2 and 3, a random sample of 50 5th grade students in
each of the 60 selected schools (total n=3,000) will be surveyed at 6-month intervals over 3 years for a total of
6 assessment waves. Observational assessments of schools and caregiver and teacher surveys will enable
multi-informant assessment of key constructs. Longitudinal mediation models will assess the influence of
school environment factors on mental health and examine emotional, cognitive, and social processes as
explanatory mechanisms (Aim 2). Moderated mediation models will determine whether the negative mental
health impacts of adversities are buffered for children in positive school environments. Qualitative interviews
with parent/child dyads will provide contextualized information about these processes (Aim 3). We expect the
study will have a positive impact by identifying factors in the school environment that can be targeted by whole-
school interventions to promote the mental health of Tanzanian children and inform understanding of how such
interventions can be optimized to buffer the negative impacts of adversity exposure.

Public health relevance
NARRATIVE The burden of mental health disorders among children in low- and middle-income countries (LMICs) such as Tanzania is an urgent global public health issue that must be addressed by interventions that target the upstream drivers of mental illness. The objective of this study is to identify malleable features of the primary school environment that longitudinally impact mental health outcomes and foster resilience among adversity-exposed youth in Tanzania. The study will inform the development of effective whole school interventions to promote mental health among children in Tanzania and other LMICs.